Dissecting CEBPB Function with Synthetic Biology and Imaging

Project Summary
Caloric restriction and reduced mTOR signaling mitigate the adverse effects of aging. They do not translate
into effective anti-aging therapies though, because diets are difficult to maintain and mTOR inhibitors exhibit
undesirable side effects. The transcription factor CEBPB drives many of the undesirable effects of aging
downstream of the TOR pathway. The levels of its short isoform called LIP increase with age; loss of LIP
increases lifespan and provides health benefits, while expression of LIP alone increase tumorigenicity.
Reprogramming CEBPB and LIP therefore holds great promise as a tool to control aging.
Pioneering studies indicated that LIP activates transcription of its target genes, while the canonical long
isoform of CEBPB, LAP, is a transcription repressor. Recent evidence draws a more complex picture:
- both isoforms are extensively modified by phosphorylation, acetylation (and many others), and those
modifications impact their activity;
- dimerization of CEBPB with other factors impacts its function;
- finally, LIP rescues CEBPB knock-out, suggesting that LIP is not simply a dominant negative inert
isoform.
Understanding how these regulatory dimensions are integrated by CEBPB isoforms is a pre-requisite to
develop technologies able to reprogram aging.
Here, we deploy synthetic biology approaches in order to dissect how the CEBPB isoforms, their
dimerization partners and post-translational modifications impact the nuclear dynamics of CEBPB and its
transcription regulation activity.
We also develop synthetic tools to visualize and perturb the LAP:LIP ratio in individual cells. Being able to
perturb aging regulators in single cells will enable measuring the contributions of cell-autonomous aging
phenotypes and those driven by signals between cells. It will also provide precise tools to dissect one of the
common hallmarks of aging: increased heterogeneity of expression.

Public health relevance
Project Narrative Caloric restriction is emerging as a potential antiaging strategy, but diets are difficult to maintain; because pharmacological approaches leveraging the mTORC1 pathway have undesirable side effects, new antiaging therapeutic targets are needed. The transcription factor CEBPB plays a key role in aging phenotypes via changes in the relative levels of two forms of the protein, yet the molecular mechanisms these two isoforms mediate are not fully understood, limiting our ability to precisely perturb this pathway. Here we use high- throughput quantitative imaging to dissect the mechanisms of CEBPB isoforms functions, and deploy synthetic biology approach to monitor and perturb CEBPB function in individual cells.